Conjugated bile acids as nutritionally re-programmable antihypertensive metabolites

Project Summary
Hypertension is the single prominent risk factor of epidemic proportions leading to cardiovascular disease and
stroke, which comprise the top two reasons for mortality of humans in the modern age. Genetics and dietary
salt intake are the most investigated factors for susceptibility to hypertension. We recently discovered a novel
link between the composition of gut microbiota and hypertension in the Dahl Salt-Sensitive (S) rat, a rodent
model of human disease. However, except for a few metabolites such as short chain fatty acids, the
mechanisms by which microbiota trigger hypertension is largely unknown. Microbiota collaborates with the
host to produce key metabolites required for host health. Conjugated bile acids are one such class of bile
acids. They are generated by the host in the liver and deconjugated by microbiota in the gut. A bile acid
targeted metabolomics study led us to discover that conjugated bile acids are significantly depleted in
hypertension, rescuing which ameliorated hypertension. Thus, the overarching hypothesis of this proposal is
that conjugated bile acids are novel antihypertensive metabolites. To test this hypothesis, experiments
are proposed to address two important questions: First, why are conjugated bile acids depleted in
hypertension? Aim 1 will address this question. Preliminary data show that specific gut microbiota which are
known to deconjugate bile acids expand during hypertension. We propose to investigate whether such
microbiota are the culprits responsible for depleting the circulating pool of conjugated bile acids. Using novel
S rats which lack gut microbiota, studies are proposed to introduce specific microbiota to test its effect on
enhancing the circulating levels of the antihypertensive metabolites, conjugated bile acids. Aim 2 will address
the second important question, ‘What is the mechanism by which conjugated bile acids provide protection
against the development of hypertension?’ Focusing on taurocholic acid, which is a specific conjugated bile
acid depleted during hypertension, Aim 2 will test the hypothesis that taurocholic acid lowers hypertension by
targeting the gut FXR-ceramide pathway. Specifically, taurocholic acid antagonizes the bile acid receptor
Farnesyl X receptor (FXR) in the gut to inhibit the transcription of key genes required for the synthesis of the
known prohypertensive metabolite, ceramide. A novel Villin-Cre rat knock-in rat and a second novel FXR
knockout rat have been constructed and proposed as tools to study this gut-specific mechanism. Overall, this
work expands our current limited knowledge beyond the host factors and sheds important new light on how
microbiota critically modify bile acid biochemistry to amplify hypertension. Our proposal not only identifies
this problem, but also interrogates a means to mitigate it by a simple solution of enhancing circulating
conjugated bile acids as a novel putative clinical therapeutic strategy to lower hypertension.

Public health relevance
Project Narrative Gut microbiota is now recognized as a critical, previously ignored factor contributing to the development of hypertension. However, the mechanisms by which gut microbiota regulates hypertension is a significant knowledge gap. In this proposal, building on our recently published data, we address this knowledge gap on conjugated bile acids, which are products of collaborative biochemical processing by gut microbiota and the host. The proposal uses cutting-edge animal models as tools to understand the mechanism by which gut microbiota- mediated conjugated bile acids operate as antihypertensive metabolites.